Evolution of innate antiviral defense mechanisms and other microbe-driven genetic innovations

PROJECT SUMMARY/ABSTRACT
Microbes are a constant presence in our environment and impact humanity in diverse ways. In particular,
infectious diseases caused by endemic, emerging, and zoonotic pathogens result in millions of human deaths
per year. However, we only poorly understand the many mechanisms that hosts have evolved to defend
against pathogens and that pathogens have counter-evolved to defeat those defenses. Importantly, the result
of these host-pathogen evolutionary conflicts (i.e. whether the host or the pathogen is successful) ultimately
determine our susceptibility to infection. It is therefore of paramount importance that we address the following
questions: what are the critical genes and mechanisms that protect us from infection from circulating and
zoonotic pathogens, how do pathogens counteract those defenses, and how does host genetic variation affect
susceptibility to infection? Our research brings an evolution-guided perspective to answering these questions
by exploiting natural diversity in host and microbial genomes to identify genetic innovations that have been
driven by host-microbe interactions. One motivating insight for this approach is the fact that the interests of
pathogens and their hosts are necessarily at odds with one another. That is, if the host successfully defends
against a pathogen, there is evolutionary pressure on the pathogen to evolve a way to overcome that defense.
Likewise, if the pathogen establishes a successful infection, the host is pressured to adapt. These back-and-
forth dynamics drive constant innovation on both sides of host-pathogen molecular interactions, resulting in the
wide genetic and functional diversity we see today. Our research explicitly leverages this diversity to discover
which host proteins have been driven to rapidly evolve by genetic conflicts with pathogens, in effect allowing
pathogens to lead us to the host genes, mechanisms, and pathways that are most important for fitness. Our
prior work highlights the utility of this approach by identifying several novel mechanisms in host innate
immunity. Based on these evolution-guided insights, our current work focuses on the importance of several
incompletely understood post-transcriptional and post-translational regulatory mechanisms in host antiviral
defense. At the same time, we will continue to use comparative genomics, virology, and biochemistry to
identify other rapidly evolving novel mechanisms in innate immune defenses. Finally, we are using a related
evolution-guided approach to discover functional innovations in animals that result not just from adaptation to
microbial conflicts, but also from direct co-option of microbial genes by horizontal gene transfer (HGT). The
overall mission of our work is to use an evolution-guided multidisciplinary approach to provide unique insights
into mechanisms of host defense and pathogen immune evasion, species-specific barriers to pathogen
replication and cross-species transmission, and microbe-driven evolution of cellular functions.

Public health relevance
PROJECT NARRATIVE Microbes are a constant presence in our environment and impact humanity in diverse ways, yet we incompletely understand the many ways that our immune system has evolved to defends against pathogens, and the ways that pathogens evolve to avoid or defeat our defenses. This project takes an evolution-guided approach to discover new critical mechanisms that underlie host susceptibility to viral infection by identifying and characterizing human genes that have repeatedly evolved to contend with pathogen infections in the past. Such an unbiased approach will allow us to discover new players in the ongoing conflict between hosts and viruses, and leverage the diversity that is already found in nature to develop ways to diagnose, prevent and treat infectious diseases.